ANTENATAL PHENOBARBITAL IN THE PREVENTION OF NEONTAL INTRACRANIAL HEMORRHAGE

Examines if Phenobarbital administered antenatally to pregnant women less than or equal to 32 weeks gestation who are expected to deliver within 24 hours, will reduce the incidence of intracranial hemorrhage &/or ischemic brain injury, reduce the mortality rate & reduce the incidence of neurodevelopmental sequelae in the preterm neonate.